Eneza Data Science: Enhancing Data Science Capability and Tools for Health in East Africa

Abstract
The Research Training program "Eneza Data Science: Enhancing Data Science Capability
and Tools for Health in East Africa" builds on Aga Khan University's UZIMA DS-I Africa project,
whose focus is to improve health outcomes for at-risk mothers and children, mental
health outcomes for at-risk adolescents and young adults in Kenya, and bioinformatics
research and capacity building programs that have grown within the Human Health and
Heredity in Africa (h3africa.org) program; Eastern Africa Network for Bioinformatics Training
(EANBiT) and H3ABioNet, the pan-African bioinformatics network. EANBiT has as the main
output masters level graduates in bioinformatics, which includes a five-week intensive
residential training program that leads to thesis research in a range of bioscience disciplines,
including infectious pathogens and vectors and microbial and human genetics. H3ABioNet
has built an accessible and distributed introduction to bioinformatics training (IBT) and
intermediate courses that often have ~1000 students simultaneously in Africa. ICIPE will lead
Eneza Data Science, building on experience gained through H3Africa, in collaboration with
Aga Khan University, and support from experts from the University of Michigan, the United
States International University in Africa (USIU-Africa, based in Nairobi); Pwani University in
Kenya, and the Open Pharma Foundation in India. This program brings together
transdisciplinary expertise in machine learning / artificial intelligence, clinical practice,
statistics, bioinformatics, and extensive knowledge of infectious diseases in the tropics. We
have structured Eneza Data Science as a reproducible short-term training and internship
pipeline to enhance data science capabilities measurably and provide opportunities to grow
collaboration across communicable and noncommunicable diseases research and clinical
communities in the region. Eneza is a Swahili word that means 'spread' or 'disseminate', and
our vision is that we will incrementally contribute to individual skills and the number of trained
health sector personnel who apply data science tools to improve decision making in healthcare
service settings. The program specific aims are: Aim 1: Develop a collaborative platform for
promoting and strengthening data science for health training and career development; Aim
2: Build awareness of the need for data science for health through engagement among
stakeholders to grow the application of data science tools in clinical settings; Aim 3: Design a
training model that combines short courses, hackathons, and mentorship programs to build
capacity for clinicians, researchers, trainers, and trainees.

Public health relevance
Project Narrative The Research Training program “Eneza Data Science: Enhancing Data Science Capability and Tools for Health in East Africa” will build on existing and new partnerships in data science, enabling system thinking across disciplines in clinical practice, and health research in an integrative approach. ICIPE will lead the program, with partners in Kenya (Aga Khan, USIU- Africa and Pwani universities), and international partners in the University of Michigan and Open Philanthropy, to enhance data science skills so that information in raw and often disparate data can be harnessed for healthcare improvement. The Eneza Data Science project aims to empower clinicians, health personnel, health researchers, and data science researchers with open science skills and tools to turn data into meaningful insights for better health, building on collaborations developed through the Human Heredity & Health in Africa, and the UZIMA DS-I Africa project hosted at Aga Khan University (Kenya) to 1) build a robust research and training platform, 2.) enhance data science knowledge, and 3.) build skills in data science, in order to benefit in Nairobi.